A Systems Approach to Targeting Innate Immunity in AD

Our funded U01 project in the AMP-AD consortium had the overarching aim of identifying therapeutic targets
within innate immunity pathways. In the previous funding period, we made significant progress and met all
milestones of our U01. We have nominated multiple targets in the immune system, and these targets are at
various stages of validation. Nevertheless, key gaps in our understanding impede transformation of the collective
AMP-AD knowledge to validated therapeutic targets. Despite identification of numerous perturbed transcriptional
networks, some enriched for Alzheimer's disease (AD) risk genes, key tractable targets in these networks are
not unequivocally identified and validated. Further, whether the observed transcriptional changes are a simple
consequence of disease or actually, play a role in the pathologic cascade has, typically, not been determined.
Finally, the direction of molecular changes that is beneficial vs. detrimental has, in most cases of nominated
targets, not been established. To overcome these gaps in knowledge, we will i) leverage unique aspects of our
existing data and tools along with data and analyses generated by the larger AMP-AD consortia, ii) generate
complementary new data, and iii) apply innovative analytic approaches. Notably, our ability to perform
comparative analysis of control (no pathology), PathAg, (Pathologic Aging, amyloid+), AD (tau+, amyloid+) and
PSP (progressive supranuclear palsy, tau+) enables a framework to identify therapeutic targets that play a role
in the transition to different disease stages of AD. Further, comparisons between two brain regions
(TCX=affected and CER=largely spared in AD) and between AD and PSP can help distinguish whether the
molecular changes identified are likely a cause or consequence of pathology. In this renewal application, we
propose to: i) refine and genetically validate therapeutic targets ii) identify molecular mechanisms and targets
that mediate disease transition from control to PathAg to AD iii) define the drug target mechanism(s) iv) evaluate
select prioritized targets in relevant models, v) continue the collaboration with all AMP-AD partners to promote
consortium wide-target validation and vi) share our data openly with the larger scientific community. These
studies will include the final phase of modeling studies for more than 20 immune targets identified in the original
grant cycle with a goal of making firm go, no-go, decisions on select targets. These studies will enable us to i)
provide biologic insight into the mechanism of action of the proposed targets and ii) inform on the direction of
change needed for therapeutic benefit. Identification of key targets that drive the transition from control to
amyloid positivity, and then to tau pathology and neurodegeneration will enable us to propose alignments of
future clinical testing of therapeutics that manipulate these targets in appropriate disease stages-increasing the
likelihood to achieve clinical efficacy and avoiding costly testing of an agent in an intent to treat population that
is unlikely to benefit.

Public health relevance
Given there are no approved disease modifying therapies, and the personal, societal, and economic toll of Alzheimer's disease (AD) continues to increase there is a huge unmet medical need. Generation, mining and sharing of information from system level data; with widespread collaborative validations in other human data and model systems provides novel insights to the disease processes. This data we will use to identify and validate novel therapeutic approaches for AD.